Role of intracellular organelle homeostasis in adaptation to dietary restrictive interventions

Our long standing interest in the biology of Siruin deacylase enzymes and BLOC1S1 have converged on their nutrient-sensing role in modifying intracellular organelle homeostasis to modify immune regulatory function in both innate and adaptive immune cells. The mouse based studies explore this organelle biology in the context of inflammatory and immune linked disease processes. This project aims to integrate intracellular organelle signaling and immune regulation and our current disease models include atopic dermatitis, asthma and murine influenza (collaborative study).